REGULATION OF ANAL MOTILITY

The objectives of this study are to elucidate the mechanisms which regulate anorectal motility and continence in health and to determine whether these mechanisms are altered after ileal pouch- anal anastomosis. We will 1) attempt to identify a suitable manometry apparatus for long-term monitoring of anorectal function and 2) perform studies to determine the effects of the interdigestive myoelectrical complex and fed and fasting states on anorectal function.